Predictive utility of polygenic risk scores for chronic kidney disease.

ABSTRACT
In this application for a 5-year K25 Career Development Award, I propose a mentored research and career
development plan providing a foundation for a future career as an independent investigator in kidney disease.
The goal of this research project is to develop and test polygenic risk scores for chronic kidney disease (CKD)
and its glomerular subtypes, such as immunoglobulin A nephropathy (IgAN), membranous nephropathy (MN)
and focal segmental glomerulosclerosis (FSGS). Although traditionally genetic studies have been focused largely
on rare genetic variants associated with a high risk of disease, there is mounting evidence that common variants
have substantial polygenic contributions to the risk for common chronic diseases and these findings may have
a significant public health impact. Recent studies demonstrate that individuals in the top 1-5% of polygenic risk
score distribution have disease risk equivalent to many of the rare variants currently tested for clinically, including
mutations that are causal for diseases such as obesity, breast cancer, colon cancer, inflammatory bowel disease,
atrial fibrillation, or coronary artery disease. For example, a genome-wide polygenic risk score for BMI has been
developed and validated that uses 2.1 million common genetic variants to accurately predict the development of
severe obesity early in life. This proposal will apply similar methods to evaluate polygenic contributions to CKD
and its various subtypes for which new powerful genome-wide association studies (GWAS) datasets are
presently emerging from our lab (I am co-author of most of the studies by contributing data from eMERGE and
UK biobank consortia). With guidance from my mentors, I have drafted a 5-year career development plan that
includes training in clinical domain knowledge of kidney disease and its subtypes including familiarity with the
pathogenesis models for common kidney disorders and potential clinical applications of polygenic scores in
nephrology (primary-mentor: Dr. Krzysztof Kiryluk), biomedical informatics (co-mentor: Dr. Chunhua Weng) and
novel statistical genetics methods for the analysis of multidimensional genetic and phenotypic data (Dr. Iuliana
Ionita-Laza). In the last two years of the award I will apply for R01 funding and transition to independence. The
proposed activities will prepare me to conduct patient-oriented and biomedical research to discover novel genetic
risk factors for CKD and early diagnosis strategies for CKD and its major subtypes.

Public health relevance
PROJECT NARRATIVE Chronic kidney disease (CKD) affects 10-15% of the population world-wide and is associated with high mortality. We propose to develop and validate polygenic risk scores for CKD and its subtypes to aid in the early detection of kidney disease, before its onset, providing orthogonal risk information to the traditional disease risk factors. This proposal will lay groundwork for potential use of polygenic predictors of kidney disease in a clinical setting.